6-week trial of oxytocin for co-occurring cocaine and opioid use disorders

High rates of substance use disorders in Veterans compared to the general population
are heavily influenced by psychosocial factors – such as difficulty reintegrating into
civilian life due to avoidance of vital support systems – leading to disproportionately
elevated unmet addiction treatment needs. Those using both cocaine and heroin have
mortality rates 14.3 times higher than the general population. 30-60% of patients receiving
methadone maintenance therapy (MMT) for opioid use disorder actively use cocaine.
There are currently no approved psychopharmacological treatments for cocaine use
disorder, and drop-out rates from MMT programs and vital psychosocial treatments are
as high as 80% for cocaine users. What’s more, cocaine use, compared to other drugs, is
particularly driven by social stress, and cocaine is associated with hyperreactivity of the
hypothalamic-pituitary-adrenal (HPA) axis. Preclinical and pilot clinical findings suggest
that administration of oxytocin, a mammalian neuropeptide, may have a multitude of
direct anti-addiction effects, improve engagement in psychosocial treatments, and
attenuate hyperreactivity of the HPA axis in patients with cocaine use disorder. This is a
double-blinded, placebo-controlled, clinical trial of fifty Veterans with active cocaine use
disorder, also receiving MMT in an opioid treatment program, randomized to receive
either oxytocin 40 IU or placebo intranasally twice daily for six weeks. The primary
outcome measure will be oxytocin’s effectiveness at reducing cocaine use as measured by
quantitative levels of the cocaine metabolite, benzoylecgonine, in weekly urine samples.
Potential mechanisms of treatment response will be evaluated by measuring oxytocin’s
effectiveness at a) improving therapeutic alliance with treatment providers (Working
Alliance Inventory, client and therapist forms) and attendance in existing clinic-run
treatment components and b) attenuating social stress-reactivity by measuring self-
reported cocaine craving, psychophysiological stress measures, and salivary cortisol in
response to a Trier Social Stress Test. In sum, discrepancies between Veterans and
civilians in addiction prevalence, severity, and successful intervention are largely driven
by higher rates of social avoidance and posttraumatic stress symptoms among Veterans.
This study will uniquely combine psychopharmacological and evidence-based
psychosocial interventions targeted at reducing cocaine use, improving treatment
engagement, and preventing stress-related cocaine use among Veterans with co-
occurring cocaine and opioid use disorders receiving MMT.

Public health relevance
Substance use disorder prevalence (SUD) in Veteran populations is estimated to be almost seven times higher compared to civilians. 25% of Veterans 18- to 25-years-old returning from Iraq or Afghanistan in the past ten years met full criteria for a SUD diagnosis when presenting to care for the first time, and only 11% of them had their addiction treatment needs met. These discrepancies in addiction prevalence, severity, and intervention between Veterans and civilians are known to be heavily influenced by psychosocial factors, such as low adherence to available treatment programs, mental health stigma within military culture, and general problems with reintegration into civilian life. Avoidance behavior is highly prevalent among Veterans and increases the risk for both posttraumatic stress symptoms and SUDs. An integrative intervention that would address addiction-related neural processes, engagement in vital psychosocial treatments, and improve stress regulation would greatly benefit Veterans with SUDs.